Tyrosine Phosphatase Regulation of Mucosal Macrophage-Epithelial Cell Cross-talk

SUMMARY/ABSTRACT
Mucosal surfaces are under constant challenge from exposure to environmental or microbial agents. However
the exact nature of interactions between innate immune cells in the regulation of the mucosal barrier is still
poorly understood. This proposal will incorporate a team of investigators with diverse and complementary
expertise to investigate the mechanisms of innate immune cross-talk in the regulation of mucosal barrier
function. The single layer of epithelial cells lining the GI tract is the most fundamental element of the mucosal
barrier while macrophages play a key role in mucosal barrier homeostasis and in immunity to intestinal
pathogens. Previous studies of communication between these intestinal epithelial cells (IEC) have focused on
unidirectional macrophage regulation of epithelial function. However, we believe that this view is overly
simplistic and that a more complex regulatory circuit exists. We hypothesize that bidirectional cross-talk
circuits between epithelial cells and macrophages play a key role in both homeostatic regulation of epithelial
permeability and macrophage polarization. Here, we will investigate the molecular nature of bidirectional cross-
talk circuits between epithelial cells and macrophages with the overall objective to identify how the cell-intrinsic
activity of an essential protein tyrosine phosphatase (TCPTP) regulates molecular changes in one cell type,
which can in turn modify the functional capacity of the other. We will test our hypothesis in 3 Specific Aims.
Aim 1 will address how TCPTP modulates the monocyte differentiation continuum and macrophage
polarization status in mucosal homeostasis vs. local inflammation in the intestine. Aim 2 will utilize adoptive
transfer experiments to identify how TCPTP deletion in macrophages vs. IEC modulates intestinal permeability
and antimicrobial responsiveness of both cell types in vivo and in vitro. Aim 3 will identify molecular
mechanisms by which TCPTP regulates how these cell types cross-communicate with each other. We have
established novel mouse lines and in vitro co-culture model systems for this study. We will use these model
systems in a series of innovative and established approaches, to allow us to mechanistically define
phosphatase regulation of these fundamental interactions between macrophages and epithelial cells in the
regulation of mucosal barrier function and macrophage polarization. In addition, we will identify if these cell-
intrinsic phosphatase regulated crosstalk mechanisms apply across species by using mouse and human model
systems. These experiments are foundationally linked to prior work but unequivocally represent an exciting
new direction that synergizes the expertise of the investigative team. The results from these studies are
poised to generate significant advances in our understanding of fundamental basic mechanisms in innate
immunobiology and cellular crosstalk at mucosal surfaces.

Public health relevance
NARRATIVE This proposal will investigate how epithelial cells that line mucosal surfaces, and macrophages that are a key innate immune cell involved in host defense against infection, communicate with each other to cross-regulate each other’s function in homeostasis and following microbial challenge. We will investigate how modification of an essential protein tyrosine phosphatase in one cell type changes the behavior of the other cell using novel model systems with complementary in vivo and in vitro approaches. In addition, we will identify novel mediators and mechanisms of cellular cross-talk that are vital for macrophage polarization, epithelial barrier maintenance and protection against infection at mucosal surfaces.